Placental Insulin Signaling and mTOR Nutrient-Sensing Programming of Offspring Metabolic Health

Both genetic and environmental factors contribute to the development of Type 2 diabetes (T2D).
Hyperinsulinemia is commonly seen among pregnant women with prediabetes, obesity, and gestational
diabetes, and their offspring has a greater risk for developing T2D. Yet, no current study addresses the
long-term/longitudinal metabolic outcomes of the offspring when the mother is hyperinsulinemic.
Furthermore, the mechanistic link between maternal hyperinsulinemia and the programming of
metabolic disease in the offspring remains largely unknown. The dogma is that insulin does not cross
the placenta into the fetus to regulate fetal growth. However, maternal insulin can act as a growth factor
and an anabolic hormone binding to the placental insulin receptor (IR) and insulin-like growth factor 1
receptor (IGF1R) to drive critical placental function, including nutrient flux to the fetus. Thus, maternal
insulin can change placental function by altering nutrient availability to fetal metabolic tissues causing
permanent changes that predispose the offspring to T2D in adulthood. Indeed, we have compelling
preliminary data showing increased body weight and glucose intolerance in the offspring of
hyperinsulinemic dams. We identified that placental-specific IR deletion has a beneficial effect in
improving glucose tolerance in the offspring of hyperinsulinemic dams. These observations provide a
strong premise that the placenta integrates maternal hyperinsulinemia signals with placental function
(i.e., nutrient flux and placental inflammation) to the growing fetus, thereby programming the metabolic
health of the offspring. In this supplemental award, we will test the main hypothesis that the increased
body weight and glucose intolerance programming in the offspring by maternal hyperinsulinemia is
caused in part by increased placental inflammation. To test that maternal hyperinsulinemia programs
metabolic dysfunction in offspring by accelerating the proinflammatory phase of placental development
during gestation, we will perform the following two specific aims: Aim1: Investigate whether maternal
hyperinsulinemia, in the absence of hyperglycemia and obesity, is sufficient to alter immune cell
composition and potentiate placental inflammation. Aim2: Examine the metabolic health trajectory of
offspring born to dams with hyperinsulinemia to assess if placental inflammation can lead to the
predisposition of metabolic diseases. These studies are highly significant because they will define the
molecular mechanisms whereby maternal hyperinsulinemia impacts metabolic health, and they
underscore the importance of clinically controlling insulin levels during pregnancy, like glucose, to
improve pregnancy outcomes. Thus, the anticipated success of this project will have significant
implications in improving women’s reproductive health and the metabolic health of the offspring.

Public health relevance
Pregnancy conditions such as prediabetes, obesity, and gestational diabetes mellitus can exacerbate maternal insulin levels causing changes such as placental inflammation, which can mal-program fetal metabolic tissues and predisposing the offspring to metabolic disease in childhood and adulthood. Yet, very little information is known about the role of insulin signaling in placental inflammation in the offspring of dams with hyperinsulinemia. We expect that the results from the proposed work will ultimately lead to new understanding of the effects of high maternal insulin during pregnancy on placental inflammation that may cause programming of metabolic disease, and this new knowledge could improve clinical management of patients, and thus improve women's reproductive health and pregnancy outcomes.